PHASE I TRIAL OF AG-331 IN PATIENTS WITH REFRACTORY SOLID TUMORS

To determine the tolerance, in patients with refactory solid tumors, to treatment with AG-331, a novel inhibitor of thyridine synthetase.